The relationship between maternal ZIKV-specific and ADE antibodies and fetal outcome

ABSTRACT The World Health Organization declared the Zika Virus (ZIKV) epidemic that began in Brazil in 2015 and rapidly spread to surrounding countries in the Americas and Caribbean an international public health emergency. The most concerning feature of this global epidemic, which is primarily being spread by the Aedes species of mosquitos, is its association with fetal brain damage in infants, manifesting as microcephaly and other neurologic deficits. Thus, it is a global priority to rapidly develop strategies for prevention of maternal infection, primarily a maternal ZIKV vaccine that can protect women from ZIKV infection and/or the associated fetal disease. Yet, the lack of understanding of the natural maternal immune responses to ZIKV infection and how they relate to fetal outcome will impede vaccine development. Virus-specific antibodies are often critical for protection against virus acquisition and are passed to the fetus during late pregnancy, yet pre-existing antibody responses against dengue virus, a predominant co-circulating flavivirus, can have detrimental effects on dengue disease pathogenesis via antibody-dependent enhancement (ADE). Thus, we hypothesize that the presence of cross-reactive maternal antibodies that can mediate ADE or placental cell transfer and the magnitude and potency of the ZIKV-specific maternal antibody response predict the severity of fetal ZIKV infection in a prospective, multi-national pregnancy cohort in Victoria, Brazil and Singapore, Singapore. We have assembled a global, highly skilled team with expertise in maternal-fetal viral infection, obstetric clinical trials, and immunology involving emerging infections and more specifically flaviviruses. Understanding the relationship between maternal antibody responses, in utero virus transmission, and fetal outcome is critical to defining the immunologic roadmap for a maternal ZIKV vaccine.

Public health relevance
PUBLIC HEALTH NARRATIVE The recent Zika Virus (ZIKV) epidemic in the Americas and its association with birth defects prompted a global health emergency response, the most important of which is rapid development of an effective vaccine that will protect against congenital ZIKV transmission. However, an understanding of the relationship between the maternal immunity and fetal outcome is critical to defining the immunologic targets of vaccine. Moreover, as cross-reactive antibody responses are known to enhance disease after infection with the co-circulating flavivirus dengue (DENV), it is critical to know whether similar antibody enhancement contributes to ZIKV- associated fetal disease. In this study, we will assess the relationship between maternal ZIKV-specific and cross-reactive antibody responses and fetal outcome in ZIKV-infected pregnant women in 2 geographically distinct regions of ZIKV transmission: Victoria, Brazil and Singapore. This work will inform the types of antibody responses that should be induced by an effective ZIKV vaccine.